MARC at East Carolina University

Project Summary
Drawing from the rich ethnic diversity of our rural region, we propose to establish a new interdisciplinary
undergraduate (UG) training experience at East Carolina University (ECU). Our program will enhance STEM
retention and matriculation in PhD and MD/PhD programs by maximizing research opportunities for diverse
underrepresented (UR) and disadvantaged students interested in biomedical careers. Known nationally for its
high ranking in social mobility index and cost-effective education, ECU is a ten-time winner of the Higher
Education Excellence in Diversity Award and an ideal environment to foster the professional development of UR
students. Our program goals address local and nationwide disparities in STEM education: the dearth of UR
students pursuing graduate studies and the loss of UR students from STEM majors in the first two years of
baccalaureate training. We will establish a new two-phased MARC Program at ECU (MARC@ECU), drawing
from more than 700 exceptionally qualified undergraduates. Phase 1 (pre-MARC) begins with career exploration
for prospective students at college orientation sessions and culminates with a new Sophomore level course
(Introduction to Research) and innovative new Research Shadowing Program, both designed to make the
process of research more visible and tangible. From this pool of students, we will recruit six Junior level students
annually into the MARC-funded Phase 2, where trainees complete a structured interdisciplinary curriculum in
their major of interest focused on science communication, rigorous scientific methods and analyses, and
professional development in preparation for doctoral careers. Mentored undergraduate research experiences
are well-established high-impact practices that prepare students for doctoral programs and are the centerpiece
of our program, culminating in student composition of a Disciplinary Honors Thesis suitable for publication.
Leveraging the unique resources at ECU, including a university-level Office for Undergraduate Research, the
MARC@ECU draws together 31 diverse faculty mentors whose work generally falls into four major sub-
disciplines of biomedical research. The MARC@ECU will build a stronger, more collaborative research
community among UG researchers by pairing them with peer and faculty mentors in a mixture of social and
professional development activities and expanded alumni networking opportunities. Although only six students
from each cohort will receive MARC support, the other students in each Phase 1 cohort well be well-prepared
for other related programs designed to support UR students in STEM already in place, including more than 14
sections of team-centered course-based undergraduate research experiences. In the long-term, these
programs along with MARC will help ECU enhance our inclusive environment and foster an immersive
undergraduate research community that will nurture our students to develop their innate skills and strengths.
The MARC program is an important next step towards creating an institutional shift towards advanced degrees
in biomedicine that are likely to have long-lasting impact on our region.

Public health relevance
Project Narrative We seek to establish a new MARC Program at East Carolina University (ECU) to provide an innovative and collaborative training environment that fosters professional development for underrepresented and disadvantaged undergraduates towards biomedical careers that require PhD and MD/PhD degrees. The program combines high-impact educational experiences for undergraduates with a strong interdisciplinary biomedical research program spanning nine departments in the College of Arts and Sciences and the Schools of Medicine and Dental Medicine. The program will broaden career options in biomedical sciences for undergraduates particularly from first-generation and ethnic minority backgrounds, which will increase social mobility and support the rapidly expanding regional biomedical and biopharmaceutical industry in the region.